Dissecting stress modulation of pnVTA nociceptin peptide-mediated approach-avoidance behavior

PROJECT SUMMARY: Chronic stress contributes to the pathogenesis and exacerbation of numerous disorders
that frequently present with atypical motivation during reward-seeking behavior including substance use disorder
(SUD), major depressive disorder (MDD), and anxiety. The extent to which motivation is disrupted by stress can
depend on the form of stress exposure. Hence, it is critical to understand the neural circuitry regulating motivated
behaviors become disrupted under diverse chronic stress states to improve our understanding of how these
disorders develop, what makes some individuals more susceptible, and to identify more effective molecular
therapeutic targets. Our laboratory previously reported that neurons producing the endogenous opioid peptide
nociceptin in the paranigral ventral tegmental area (pnVTAPnoc neurons) act locally on nociceptin receptor
(NOPR) to limit motivation for reward (Parker et al, Cell, 2019), while others have identified a role for nociceptin
signaling in the orchestrated stress response. Preliminary data show that pnVTA nociceptin neurons are
dynamically engaged to different extents by distinct stressors. The central hypothesis of this proposal is that
stress differentially engages pnVTA nociceptin signaling to regulate the expression of motivated behaviors such
as approach-avoidance. This proposal is in direct response to NIDA’s Strategic Goal 1 which aims to investigate
circuitry contributing to brain functions “such as reward, motivation, decision-making…and stress reactivity, ”
alongside examining a NIDA high priority target for SUD. Aim 1 will determine how diverse physical and
psychological stressors alter the VTA nociceptin opioid system on a molecular and functional level. Aim 1A will
evaluate how various stressors acutely and chronically alter VTA nociceptin/NOPR expression and neuron
activity. Aim 1B uses a new genetically encoded biosensor for the nociceptin peptide (NOPLight), and head-
fixed approach-avoidance (Ap-Av) behavioral models to determine how nociceptin release in the VTA is altered
during Ap-Av decision making following stress exposure. Aim 1C uses prepronociceptin (Pnoc) conditional
knockout line created in-house and optogenetics to manipulate VTA nociceptin peptide expression and activity
following stress. Aim 2 will determine the anatomical and functional involvement of the lateral hypothalamus
(LH) as an afferent input regulating pnVTAPnoc neuron activity in naïve and stressed states using
electrophysiology and fiber photometry to simultaneously record LH terminal activity and nociceptin release in
the VTA following chronic stress exposure. Leveraging these new approaches will enable us to provide brand
new insight into this poorly understood system. During my training period I will learn to utilize cutting-edge
techniques in order to perform powerful, high-resolution investigations of neuropeptide circuitry, and gain
valuable career development training across a host of scientific, intellectual, and mentored programming. This
F31 mechanism will allow me to pursue my individual development plan and prepare me for a career as an
independent neuroscientist.

Public health relevance
PROJECT NARRATIVE Chronic stress is a prominent factor in the development of aberrant reward-seeking behavior in disorders like substance use disorder which affect an alarming proportion of the global population, yet we lack a basic understanding of the innate neurocircuitry that are disrupted by stress exposure which subsequently alters motivation to seek rewards. We have recently identified a nociceptin neuropeptide and receptor circuit that suppresses reward-seeking and increases aversion, central components of approach-avoidance behavior. The goal of this proposal is to investigate how the endogenous ventral tegmental area nociceptin opioid circuit is engaged by diverse forms of stress exposure to regulate the expression of approach-avoidance behaviors, opening new avenues for exploring nociceptin receptors as a viable therapeutic target for reward-related disorders.